Bone-targeted delivery of TGFβ inhibition for osteoarthritis

Abstract
Osteoarthritis (OA) is the most common degenerative joint disorders and the leading cause of physical disability.
There is no effective disease modifying treatment for OA except the joint replacement surgery. We have revealed
that aberrant subchondral bone remodeling leads to degeneration of joint articular cartilage. Elevated osteoclast
resorption in the OA subchondral bone leads to excessive TGFβ1 that uncouples bone resorption and formation
and resulted in deterioration of subchondral bone. Restoring the structural integrity of subchondral bone by
inhibiting TGFβ activity in subchondral bone can prevent OA progression and cartilage degeneration.
Pain is the most prominent symptom of OA that urged people to seek for medical care. Our preliminary study
suggests that osteoclasts derived factor induces axonal extrusion and innervations in the subchondral bone and
substantially contribute OA pain. Zoledronic acid, a bisphosphonate that inhibits osteoclasts activity, has been
reported effective in reducing knee pain and the BMLs size.
Suppressing of TGFβ signaling pathway with type I TGFβ receptor inhibitor has been demonstrated to rescue
subchondral bone pathology and attenuate cartilage degeneration. However, TGFβs are multifunctional
cytokines that are involved in a range of biological processes. Systemic inhibition of TGFβ signaling may lead to
a failure in the maintenance of tissue homeostasis of other organs, particularly articular cartilage where TGFβ
severs as a major anabolic factor. Thus, it is of great importance to develop a novel strategy that can retain or
perhaps even increase the efficacy of the TGFβ inhibitor while improving its safety in the therapeutic applications.
We have synthesized a novel drug that conjugates alendronate (ALN), a bisphosphonate drug, with LY 2109761
(LY), a selective TβRI and TβRII kinase inhibitor, through a metabolically cleavable linker. Utilizing the high affinity
of ALN, we achieve bone targeted delivery and sustained bone release of TβR inhibitor. Moreover, we anticipate
that this conjugate has superior effect in alleviating OA pain as ALN has also been known to relieve bone pain.
In this application, we propose to investigate the effects of the conjugate in preventing the development of
osteoarthritic pathologies as well as alleviating joint pain. We will also optimize the treatment dosage, frequency
and evaluate the toxicity of the conjugate in OA animal model. The results are expected to provide a strong
technological and theoretical foundation for future clinical trials.

Public health relevance
Osteoarthritis is a common joint degenerative disease that causes a huge economic burden. Currently there is no effective disease-modifying treatment for OA. Osteoclastic bone resorption induces OA pain and excessive TGFβ activation, which consequently contribute to subchondral bone deformity and cartilage degeneration. We are working to develop a patent-protected novel conjugate drug by combination of the TβRI inhibitor with a bisphosphonate drug, which inhibits osteoclast activity and has a high affinity to bone. The success of the conjugate may highlight an unmet need for effective therapeutic approaches with minimized side-effects and chemical toxicity for OA patient.